Antiviral treatment of BK polyomavirus reactivation

Project Summary
BK polyomavirus (BKPyV) associated nephropathy (PVAN) is the leading cause of kidney transplant
loss (~10%/year). BKPyV infects approximately 80-90% of people during childhood and is kept in check by
the host immune system. However, in transplant patients BKPyV reactivation causes PVAN due to
suppression of their immune system. The current treatment is reduction of immunosuppression, which
increases the risk of graft rejection, but untreated PVAN will result in allograft loss. Patients are routinely
monitored for BKPyV in the urine and the plasma, providing an opportunity to treat early with antivirals,
before decreasing immunosuppression is required. Based on our mechanistic studies, we have identified
two host pathways required for BKPyV production in primary kidney cells that, when inhibited by existing
drugs, reduce viral titers.
We discovered that bortezomib, a proteasome inhibitor, potently decreases viral titers by 3 logs, at
low doses and without affecting cell fitness. We will also test newer generation proteasome inhibitors that
are less toxic and/or orally available, carfilzomib and ixazomib.
Given that the proteasome is required early during infection, we sought to inhibit a second host
target that would reduce viral production late in infection, or could potentially eliminate virally infected cells.
BKPyV requires activation of the DNA damage response (DDR) for cell cycle arrest, to prolong S phase for
viral replication and assembly. Inhibiting the DDR activating kinases (ATM and ATR), forces BKPyV
infected, but not mock infected, cells exit S phase, and viral titers are reduced.
Our studies revealed two potent targets, the proteasome and the DDR, which both have known
inhibitors, one is already FDA approved, and the other is in clinical trials (both are being used for other
indications). The proposed aims will determine the effects of these inhibitors, and combinations of them, on
viral titers, cell viability and cell cycle regulation, using clinical viral isolates to infect primary renal proximal
tubular epithelial cells, which are the natural cell type infected in humans. We will sequence the virus before
and after inhibition studies to determine if there are changes to the viral genome. This proof-of-concept data
is required in order to test the inhibitor(s) in clinical trials (beyond the scope of this study) as antivirals that
can protect against graft loss caused by BKPyV reactivation. There is an urgent need for antivirals that can
either prevent or treat BKPyV reactivation prior to or in conjunction with immunosuppression.

Public health relevance
Project Narrative BK polyomavirus reactivation in kidney transplant patients results in graft loss for 10% of patients. The goal of this project is to apply our understanding of host pathways that are required by BKPyV for viral production in human primary kidney cells to determine if these can be exploited as antiviral targets. Identification of effective BKPyV antivirals the potential to treat this devastating viral reactivation without reducing immunosuppression in kidney transplant patients, which increases the risk of graft loss.